Role for UL12.5 and nucleic acid sensing in Phase I HSV reactivation

Herpes simplex virus (HSV) establishes a lifelong latent infection of neurons, periodically reactivating to
produce infectious virus. Reactivation can cause keratitis and lesions on the body surface. Furthermore,
substantial data link HSV to the progression of Alzheimer's disease, highlighting the need to develop
therapeutics to prevent HSV reactivation. However, little is known about the mechanisms regulating the
induction of viral gene expression following a reactivation stimulus. Previous studies from our lab and others
have shown that HSV reactivation is biphasic, with an initial synchronous burst of viral gene expression,
referred to as Phase I or animation because it is unique to the reactivation process. Viral gene expression
during Phase I/animation is independent of viral DNA replication and requires the host cell stress protein, DLK.
When initially discovered, Phase I/animation was also thought not to require HSV lytic proteins. However, our
lab has found that at least one viral protein, UL12.5, is required to promote expression of additional viral genes
during Phase I, suggesting that the process of animation is more complex than previously thought. However,
unlike the events during HSV lytic replication, the timing of viral gene expression and promoters used during
Phase I/animation have not been elucidated. Therefore, the goals of this project are to map HSV lytic gene
expression during animation and determine the contributions of DLK and UL12.5 to ultimately promoting Phase
I gene expression. The only known function of UL12.5 is to induce mitochondrial nucleic acid release and
subsequent activation of innate immune sensing pathways involving STING and/or MAVS. Intriguingly, we
have found that direct activation of STING can induce HSV to reactivate from a latent infection. Therefore,
based on our preliminary data, we hypothesize that UL12.5 is expressed early during animation to hijack innate
sensing pathways and promote Phase I viral lytic gene expression. In aim 1), we will map at high resolution the
lytic transcriptional units expressed during animation and the contribution of the only known host (DLK) and
viral (UL12.5) factors important for Phase I gene expression. In aim 2), we will test the hypothesis that HSV
hijacks innate sensing pathways for Phase I gene expression. This proposal is significant and innovative
because we will create the first high-resolution map of HSV lytic gene expression following a reactivation
stimulus, facilitating future investigation into the role of viral genes and host proteins in promoting exit from
latency. In addition, we will determine the contribution of the first viral protein identified that is required for HSV
Phase I gene expression. Inhibiting UL12.5 expression or its downstream mechanism of action could prevent
entry into reactivation and, therefore, limit potential detrimental effects of UL12.5 or additional viral proteins that
could ultimately promote neuronal degeneration.

Public health relevance
The mechanism by which Herpes Simplex Virus reactivates from a latent infection to cause disease is not known. This proposal will investigate viral gene expression during the initiation of reactivation and the role of the first viral protein identified that is required for exit from latency. The long-term goals are to understand how the virus co-opts cellular pathways for reactivation and ultimately identify novel therapeutic targets to prevent reactivation.